GLUCOCORTICOIDS &MINERALOCORTICOIDS ON ELECTRICAL POTENTIAL DIFFERENCE

The purpose of this study is to evaluate the effects that glucocorticoids and mineralocorticoids have on the movement of sodium and chloride (salt) across the cell membranes in respiratory cells.